Effects of GABA Co-Release on Alcohol-Induced Synaptic Plasticity

PROJECT SUMMARY
Alcohol Use Disorder (AUD) is a chronically relapsing disorder for which few effective treatments exist.
Excessive alcohol use causes a number of changes in the brain that promote increased alcohol use. One of
the regions that has been shown to be affected by chronic alcohol is the dorsomedial striatum (DMS) which is
involved in the control of goal-directed behaviors. Substantial evidence now shows that a history of alcohol
exposure results in increased excitatory transmission in the DMS and that this increases alcohol intake. This
brain region also receives inputs from the midbrain releasing the inhibitory neurotransmitter GABA which
counteracts excitatory transmission. It has recently been shown that GABA released by this projection is
synthesized by the enzyme ALDH1a1, and that acute alcohol decreases the amount of GABA released via this
pathway. In this proposal, we will test the hypothesis that loss of this inhibitory input contributes to the
pathology in AUD by causing excessive excitatory drive in the DMS. Because alterations in synaptic
transmission cause long-term changes in the relative efficiency of communication between neurons, we will
examine whether loss of inhibitory transmission results in (1) enhanced synaptic strengthening and (2) reduced
synaptic weakening of excitatory transmission. Using 2-photon microscopy, slice electrophysiology, and
fluorescent biosensors, we will mechanistically dissect the role of GABA release on synaptic plasticity. These
experiments will advance our understanding of the neurobiology of alcohol in the DMS and may lead to better
treatment strategies for AUD.

Public health relevance
PROJECT NARRATIVE Excessive alcohol use results in adaptations in the brain that can cause Alcohol Use Disorder (AUD). These changes are underlied by alterations in synaptic plasticity, or changes in the relative efficiency of communication between neurons. This project will examine how changes in co-released GABA, a type of synaptic transmission shown to be sensitive to acute ethanol, may contribute to the maladaptive changes observed after excessive alcohol use.